HLA B44 motif neoepitopes in NSCLC: Evaluating their effects on the TME and adding them to established markers in a model to predict durable benefit from PD- 1 inhibition with and without chemotherapy

PROJECT SUMMARY
Lung cancer is the leading cause of cancer related deaths in the United States and the World. We recently
demonstrated that programmed cell death 1 (PD-1) inhibitors, which lead to durable responses in a minority of
non-small cell lung cancer (NSCLC) patients, have greater efficacy in patients with charged HLA-B binding
pockets whose tumors harbor mutation(s) leading to what we have designated as motif neoepitopes. Motif
neoepitopes have an amino acid substitution in the second position of a nonamer generating a change in charge
from the wild type peptide with the resultant amino acid having a charge opposite from the HLA-B binding pocket.
To date, the immunological changes induced by motif neoepitopes have not been explored. We propose a
comprehensive evaluation of the underlying mechanism, focusing on patients with HLA-B44 supertype alleles
because of the prevalence (approximately 40% of the population) and distribution of HLA-B44 across racial and
ethnic groups. We will evaluate HLA-B44 samples in the cancer genome atlas (TCGA) to explore differences in
the tumor microenvironment (TME) among patients with or without motif neoepitopes by examining gene
expression and cellular composition by slide review and algorithms based on gene expression profiles. We will
evaluate surgical specimens from treatment naïve patients with or without HLA-B44 motif neoepitopes and
evaluate spatial signatures of the TME by multiplex immunofluorescence (MIF). We will assess multiple sections
from each specimen to identify biomarkers most significantly associated with motif neoepitopes. We will further
examine immune contextures of the TME associated with motif neoepitopes by single cell RNA-seq analysis.
To elucidate the predictive value of motif neoepitopes in early and advanced stage NSCLC patients and to
assess relevant clinical questions, we will perform analyses of patients in three separate clinical scenarios. As
whole exome sequencing (WES) and transcriptomic data is now routinely obtained in our NSCLC patients as
part of patients’ clinical care, we will analyze the presence and expression of genes harboring motif neoepitopes.
We will evaluate baseline tumor biopsies from 75 early stage patients with an HLA-B44 allele who receive
neoadjuvant chemotherapy plus PD-1 inhibition, correlating motif neoepitopes with pathologic complete
response. Among 75 advanced stage patients with an HLA-B44 allele who are receiving single agent PD-1
inhibition and 75 additional patients being treated with chemotherapy plus PD-1 inhibition, we will correlate motif
neoepitopes with progression of disease within 6 months of initiation of therapy.
Together, these studies will provide a better understanding of the TME and other immunologic changes
associated with the presence of motif neoepitopes. In addition, results could enable us to identify patients in
whom evaluation of this marker of neoantigen presentation could be utilized to select patients with clinically
relevant benefit in three separate clinical scenarios utilizing PD-1 inhibitor-based therapy. As a corollary, results
could also identify populations of patients in whom other treatment strategies should be considered.

Public health relevance
PROJECT NARRATIVE Among the 40% of patients with an HLA-B44 supertype allele, greater clinical activity of programmed cell death 1 (PD-1) inhibitors is seen when mutations lead to peptides in which a neutral or positively charged amino acid is substituted with a negatively charged amino acid, presumably based on favorable binding to the positively charged HLA-B44 binding pocket. We propose comprehensive studies to characterize the effects of these specific mutational events on the tumor microenvironment. We will also evaluate whether these specific mutational events can assist in directing patients to appropriate therapeutic approaches in both early and advanced stage non-small cell lung cancer.